Glucose homeostasis and the risk of Alzheimer's disease and Alzheimer's disease related dementias in the Multi-Ethnic Study of Atherosclerosis

PROJECT SUMMARY
Alzheimer’s disease and Alzheimer’s disease related dementias pose an enormous public health challenge. In
the absence of a cure, prevention or delay of pathology offers the most promising avenue to control the
disease. Despite growing recognition that cardiometabolic risk factors are major contributors to cognitive
decline, Alzheimer’s disease, and Alzheimer’s disease related dementias, many gaps remain in our
understanding of the mechanisms and pathways between glucose homeostasis and cognitive function. While
type 2 diabetes (T2D) is increasingly recognized as a major preventable risk factor for Alzheimer’s disease and
related dementias, intensive glucose control in T2D has not been shown to prevent cognitive decline in trials.
This finding and inconsistent results for the influence of glucose control (HbA1c) on cognitive decline pose the
question: What aspects of dysglycemia, and its inverse glucose homeostasis, increase the risk of
Alzheimer’s disease or related dementias? This study’s overall goal is to investigate the role of dysglycemia
across the glucose spectrum on incident neurocognitive markers of Alzheimer’s disease and Alzheimer’s
disease related dementias in a multi-ethnic cohort: The Multi-Ethnic Study of Atherosclerosis (MESA). MESA
enrolled 6814 men and women beginning in 2000. MESA participants have been extensively studied with
respect to cardiovascular risk factors and outcomes and MESA-MIND, a cognitive ancillary, adds
comprehensive cognitive testing and neuroimaging including brain MRI and amyloid β PET scans. MESA has
a 7th exam occurring between 2021-2023 that will be concordant with the second MESA-MIND visit. While
fasting glucose was obtained at every exam, and HbA1C and HOMA-IR measured at some exams, continuous
glucose has not been measured. Adding continuous glucose monitoring wearable technology to MESA Exam
7 and repeated two years later provides a unique and timely opportunity to answer challenging questions about
the role of dysglycemia that continue to impede the development of successful prevention strategies for
Alzheimer’s disease and Alzheimer’s disease related dementias. This study will also add new measurements
of insulin resistance (HOMA-IR). This ancillary to MESA will 1) Investigate the antecedent determinants of
glucose homeostasis (from continuous glucose monitors at Exam 7 (n=2000) and change over two years
(n=1000), 2. Determine whether continuous glucose markers of glucose homeostasis, dysglycemia, and
change over time are associated with incident neurocognitive indicators of Alzheimer’s disease or Alzheimer’s
disease related dementias (n=2000), and 3. Investigate the contributions of dysglycemia to Alzheimer’s
disease and related dementia pathologies by sex and race/ethnicity (n=2000). Findings from this research will
identify new mechanisms for the development of Alzheimer’s disease and Alzheimer’s disease related
dementias, discover new primary and secondary prevention targets, and have the potential to change clinical
care.

Public health relevance
PROJECT NARRATIVE The precise aspects of dysglycemia and glucose homeostasis that drive the risk of Alzheimer’s disease and Alzheimer’s disease related dementias are unknown, hampering development of successful prevention strategies. The proposed research will leverage wearable technology to investigate the association of glucose homeostasis, from continuous glucose monitors, with incident neurocognitive indicators of Alzheimer’s disease and Alzheimer’s disease related dementias in the Multi-Ethnic Study of Atherosclerosis. This study will suggest new mechanisms of Alzheimer’s disease and Alzheimer’s disease related dementia development, identify new primary and secondary prevention targets, and have the potential to change clinical care